Research Education Component

The REC supports career development, mentoring, and research training for early-stage investigators to
transition to independent research careers. Our program serves multiple institutions in San Antonio, the 7th
largest city in the U.S. and one of the largest Hispanic majority minority cities – reflecting the future demographics
of the U.S. The OAIC is the focal point for geroscience research training for the South Texas region.
Our overall goal is to foster development of early-stage investigators in translational geroscience. Scholars
will have a comprehensive skill set to test aging-modulating interventions in older adults. Our REC program was
successfully established within the last 4 years to 1) enhance clinical and translational research knowledge and
experience of basic scientists; 2) develop mechanistic research skills of clinical investigators; and 3) facilitate
collaborations among basic and clinical researchers. This goal is achieved through the following Aims:
Aim 1: Oversee the recruitment, selection, monitoring, and evaluation of a highly qualified, dedicated and diverse
group of early-career REC Scholars; assisting with their development into clinical and translational scientists in
geroscience who can effectively lead and contribute to interdisciplinary research teams.
Aim 2: Provide active multi-disciplinary supervising (mentoring) teams that regularly monitor, evaluate, and guide
the progress of each REC Scholar through their research and career development programs; Scholars and their
mentors will develop individualized structured research education plans with clearly defined responsibilities and
milestones based on their investigative needs and focused on cross-training in translational sciences.
Aim 3: Recruit and advance the careers of a diverse cadre of Scholars across multiple dimensions, including
women, underrepresented minorities and active-duty military and veterans representative of our patient
population to build a geroscience workforce with expertise in medicine, nursing, psychology, pharmacy and other
health care disciplines necessary for advancing geriatric care in a team science environment.
Aim 4: Promote cross-fertilization and assure integration of the REC participants' career development and
activities with a) all San Antonio OAIC programs and b) the national OAIC network.
Our Core has two customized tracks: the OAIC Phase 1 Program provides salary support, intensive
mentoring and didactics in translational geroscience to a diverse cadre of early-stage investigators. Phase 2
provides continued career development activities for Scholars finishing Phase 1 and early-stage faculty
emphasizing growth in independence leadership and mentoring skills. The REC trains the next generation of
scientists in geroscience by weaving together the robust and unique aging research resources and research
education programs in South Texas into an integrated enhanced career development environment. We are well
positioned to translate healthy aging strategies developed in rodents and tested in marmosets to promote
healthspan and accelerate progress in the new discipline of translational geroscience.